HIV Redirecting Innate Immunity by Vpu Targeting of JAK1

Project Summary/Abstract
It is well known that the pathogenesis of HIV is intricately linked to the immune system. For HIV to promote its
replication and long-term infection HIV must also modulate cytokine signaling to manipulate the immune
microenvironment HIV is existing in. In our previous work we have found that HIV has encoded accessory
genes that are able to block the action of the important innate antiviral cytokine named Type I Interferon. Type
I Interferons were named for their ability to interfere with the replication of viruses and HIV has encoded
multiple ways to block this cytokine. The overall goal of this R03 application is to determine how one of the
HIV-encoded genes that blocks Type I Interferon can block this signaling in T cells, the major cell infected by
HIV. Long term, this work is critical to set the stage to better understand how HIV sustains itself in a person
and avoids elimination by the innate immune system.

Public health relevance
Project Narrative HIV is able to avoid detection and elimination by the immune system as part of its main methods to survive inside a person. This proposal aims to understand how HIV targets components of the immune system to disarm the innate immune system to stay inside a person living with HIV.